Mapping Mechanosensory Circuits from the Bladder to Barrington's Nucleus

Project Summary:
Detecting sensations from within our bodies, a process called interoception, is critical to drive
many physiological processes. In the lower urinary tract, mechanosensory neurons monitor
bladder fullness. Stretch from the bladder and urethra drives local and supraspinal reflex arcs for
efficient urination, and the bladder fullness state is used by the central nervous system (CNS) to
inform us of how urgent it will be to find a restroom. Furthermore, urination is a tightly controlled
form of communication for many mammals, and humans control the urge to urinate until finding
an appropriate time and place. Thus, the urinary tract switches between two modes: storage and
voiding, and mechanical signals from the bladder are instructive, but not prescriptive for switching
to a voiding mode.
We will harness our knowledge of the micturition reflex pathway, and of the peripheral
mechanisms of mechanosensation, to explore the precise brain circuits that encode bladder
fullness and to map their dynamic activity patterns as the bladder fills. We will use immediate
early gene activity, RNA sequencing techniques, fiber photometry and cellular-resolution calcium
imaging to identify the CNS nuclei and cell types that respond to low versus high bladder stretch.
By combining these tools with machine-learning algorithms to track behavior, we can delineate
how these signals are transmitted to the pontine micturition control center (Barrington’s nucleus)
to ultimately control urination. Together, this work will map interoceptive responses from the
periphery all the way through the central control centers in the brain, and provide us with a
roadmap to understand how the brain senses and commands the body.

Public health relevance
Project Narrative: We will determine how the brain integrates bladder signals to control urination, which will provide conceptual advances in understanding bladder interoception – the sensation of internal stimuli – and its role in shaping behavior. The proposed research is a critical first step to developing fundamental knowledge about the signals from the lower urinary tract (LUT) that can increase or decrease the urge to urinate. This may yield improved pharmacologic and therapeutic approaches to help the many individuals who suffer from LUT disorders prevalent with normal aging, or with urinary tract infections, brain or spinal cord injury, and also a host of neuropsychiatric and neurodegenerative disorders such as Multiple Sclerosis, Parkinson’s disease, and Alzheimer’s disease.